Causes and Consequences of Healthcare Inefficiency in Alzheimer’s Disease and Related Dementias

Motivated by soaring spending and stagnating life expectancy, the first 20 years of this Program Project Grant (PPG) has focused on the causes and consequences of healthcare efficiency in the U.S. This work has advanced fundamental scientific knowledge regarding sources of inefficiency and has motivated significant changes in healthcare policy and delivery for millions of Americans. This competitive renewal responds to the NIA’s prioritization of Alzheimer’s disease and related dementia (ADRD)-related research by shifting the focus of this PPG to inefficiency in healthcare services and delivery for persons with ADRD. Recent PPG research showed excess mortality among older adults with ADRD, especially for people living in nursing homes. Differences in care delivery for patients with and without ADRD – and between subgroups of patients with ADRD – run the gamut from modifiable risks that contribute to development of ADRD, initial diagnosis and referral, ongoing treatment and support, and throughout later stages, including end-of-life care. Conceptually, the drivers of individual health outcomes will be documented among persons with ADRD from the social ecological perspective which recognizes nested ‘systems’ that interact with one another (individual, interpersonal, organizational, structural, community, and policy). This PPG renewal, therefore, proposes projects focusing on each concentric circle of this model and their interactions. Project 1 will explore state-level policy heterogeneity and its influence on access to home and community-based services for nursing home eligible adults with ADRD. Project 2 will test the hypothesis that having resident service coordinators for adults who live in affordable senior housing decreases adverse health care service use and increases home and community-based service use for low- income residents with ADRD. Project 3 will explore trends in the quality of primary care for people with ADRD and to identify modifiable policy-, system- and practice-level factors that contribute to better outcomes. Finally, Project 4 will develop a novel measure of provider diagnostic test ordering in the acute care setting and explore the impact of diagnosis on the trajectory of patients with ADRD. Projects achieve synergy by using the social ecological model to examine how interactions among the key variables examined in each project could operate together to improve outcomes and reduce healthcare inefficiency, and by relying on shared administrative, data and analysis, and methodology cores.

Public health relevance
Motivated by soaring spending and stagnating life expectancy, the first 20 years of this PPG have focused on the causes and consequences of health care efficiency in the U.S. In this competitive renewal application, we respond to the NIA’s call to focus our research exclusively on persons with ADRD. We seek to advance knowledge regarding how state and federal policies, the organization and structure of health care services, and clinical decision-making influence medical and social care received by persons with ADRD.